Planning and Evaluation Core

PROJECT SUMMARY/ABSTRACT: PLANNING AND EVALUATION CORE
The purpose of the Partnership for Native American Cancer Prevention’s (NACP) Planning and Evaluation
Core is to monitor and evaluate all partnership activities on a continuous basis as well as provide the oversight
of the selection of new Research Projects. This Core serves each of the NACP components ensuring that they
maintain a scope of work that demonstrates progress toward the overall goals for this 16- year partnership
between the Northern Arizona University (NAU) and the University of Arizona Cancer Center (UACC). The
Planning and Evaluation Core engages five entities: NACP’s Executive Committee (EC) made up of the
multiple Principal Investigators (MPIs), Core Co-Leaders, the professional evaluator and Partnership
Managers; the Internal Advisory Committee (IAC) consisting of research and education leaders from both
institutions outside the direct responsibilities of NACP; the Community Advisory Committee (CAC),
composed of community members that hold leadership positions within tribes; the Program Steering
Committee (PSC), an external advisory board comprised of nationally recognized experts in cancer research,
health disparities including Native American-specific cancer disparities, and training of biomedical researchers,
and the officers and leaders of the National Cancer Institute’s
Center to Reduce Cancer Health Disparities
(CRCHD) and its
Partnerships to Advance Cancer Health Equity (PACHE) program. The EC, IAC, CAC,
PSC, and CRCHD will provide expert, unbiased, rigorous evaluation of partnership progress and recommend
improvements and new directions as NACP evolves. The Planning and Evaluation Core will focus on the
following Specific Aims:
Aim 1. Build and maintain an interactive and comprehensive feedback system using mixed methods data to
allow leadership to employ data-driven formative development and summative evaluation of all NACP
components.
Aim 2. Engage the IAC in internal planning and assessing of NACP’s research and core activities to align and
leverage the strengths of NAU and the UACC.
Aim 3. Apply the unbiased and expert external evaluation and guidance of the CAC, PSC, and PACHE to
continually improve the partnership’s efforts, across all components, to reach its overall goals.
Aim 4. Utilize the IAC, CAC, and PSC in the unbiased selection of new Research Projects and monitoring of
their scientific progress.
Expected Impact: The goals of NACP are to 1) reduce the cancer burden within the Native American
population through research and community engagement; 2) expand the number of Native American
investigators working in cancer research; and 3) and increase the total number of investigators focused on
cancer health disparities within the Native American communities of Arizona.